Molecular and cellular mechanisms of circadian timekeeping in a prokaryote model

This project leverages a cyanobacterial model system to answer the following questions: what are the molecular
interactions that mark the passage of time in a cell, where do they occur in the cell, how do they mediate temporal
regulation of events, and why does biological timing matter for fitness? The circadian biological clock is an
oscillatory timer that drives 24-h rhythms of biological activities. Clock dysfunction in humans is related to a
spectrum of health conditions such as cardiovascular disease, cancer, metabolic syndrome, mental illness, and
sleep disorders. However, the circadian clock is pervasive well beyond mammals, promoting fitness in diverse
organisms throughout the phylogenetic tree. The circadian clock of the cyanobacterium Synechococcus
elongatus generates bona fide circadian rhythms of genetic, physiological, and metabolic activities that fulfill all
criteria that define circadian clocks in eukaryotes. In this genetically tractable model organism it is possible to
systematically alter the physical and biochemical properties of clock proteins and trace the impact of these
changes from their proximal effects, through the protein-interaction network, to the expressed circadian
phenotype. A new in vitro preparation comprising the oscillator proteins KaiA, KaiB, and KaiC, along with the
kinases CikA and SasA and the transcription factor RpaA, reconstitutes the circadian rhythm of binding of RpaA
to its target promoter with a real-time readout. This project will apply the in vitro clock and other technical and
conceptual advances towards biochemical, cytological, genomic, and physiological objectives that will answer
the target questions. The in vitro clock will reveal the molecular events that occur when the clock resets to an
environmental timing cue, identify the sites of action of nucleotides that modulate the timing circuit, and determine
how RpaA and a second transcription factor that is regulated by environmental signals, RpaB, work together to
influence circadian phasing. The discovery that the kinases SasA and CikA impart tolerance to fluctuating
oscillator component concentrations will overcome past hurdles for establishing a circadian circuit in Escherichia
coli as a naïve model system for exploring clock connections to cellular physiology and for biotechnology
applications. High-resolution cryo-electron tomography and focused ion-beam milling will be used to visualize
clock-controlled daily changes in intracellular organization and the clock complex itself. The molecular basis and
fitness advantage of circadian control of natural transformation will be determined. A bar-coded transposon
library first used to identify all genes required for photoautotrophic growth will be used to identify new loci that
contribute to fitness in a day-night cycle. Paired with physiological and metabolic assays, these experiments will
answer the question: why does the timing of molecular events matter? Together, these approaches will elucidate
clock mechanisms and the value of the clock to diurnal physiology, and will advance biotechnological
opportunities for controlling metabolism in both photosynthetic and traditional bacterial production systems.

Public health relevance
Narrative The project uses a simple cyanobacterial model system to ask questions that cannot be addressed as directly in animals about how the circadian biological clock keeps time, stays synchronized with the environment, and contributes to the well-being of an organism. Circadian dysfunction contributes to a range of disease states in humans, from metabolic syndrome to mental illness. Past discoveries using this system have revealed fundamentally new paradigms of protein biochemistry with relevance for diverse organisms, including humans and pathogens.